Sex-dependent innate immune mechanisms in type 2 immunity and obesity

Obesity is a rising public health concern linked to multiple preventable comorbidities, such as
worse infection outcomes, inflammatory disorders, and type 2 diabetes. Obesity affects the
immune system, and the underlying immune response is a critical regulator of its outcome. A
more common type 1 (Th1) immune response is associated with pro-inflammatory and chronic
inflammation outcomes, while the less common T helper type 2 (Th2) immune response
mediates protection. Th2 immune responses are also critical in immunity against soil-
transmitted helminth infections, which are a significant public health concern, infecting two
billion people worldwide. Identification of effector cells and molecules that promote protective
Th2 immune responses therefore have broad implications for new treatments in both metabolic
disorders and helminth infection. Significant sex differences exist in obesity and parasitic
helminth infections, however, the underlying immune mechanisms driving this sexual
dimorphism are understudied. In our recent paper we have shown that this mechanism involves
macrophage-eosinophil interactions, which are in part regulated by the RELMα protein, released
by macrophages in a sex-specific way. In this proposal we expand these results by studying
these interactions in diet-induced obesity and type 2 immunity triggered by helminth infection. In
Aim 1, we will investigate sex differences in macrophage and eosinophil function and test the
hypothesis that these innate cells protect from diet-induced obesity and helminth infection in a
sex-dependent manner. Aim 2 will determine whether myeloid cell-intrinsic RELM
α promotes
macrophage differentiation and eosinophil responses in the adipose tissue microenvironment.
Aim 3 will combine single cell transcriptomics from lab-derived data of in vitro and in vivo-
derived eosinophils with publicly available datasets to define eosinophil populations and identify
specific subpopulations and cellular pathways involved. At the outcome of this proposal, we will
have leveraged our expertise in metabolism, immunology and bioinformatics coupled with the
strengths of in vivo models and mechanistic in vitro studies with new single cell transcriptomic
technologies to determine protective type 2 immune mechanisms. Results from this study will
have broad public health implications in tackling the obesity epidemic and gaining critical
knowledge of beneficial type 2 immune mechanisms triggered by helminth infections.

Public health relevance
Profound sex differences exist in many diseases, including those that are of significant public health concern, yet studies on sexual dimorphic mechanisms underlying them are often lacking. Diet-induced obesity and soil-transmitted helminth infection are major health risks on their own and share similar mechanisms, but one (helminth infection) can protect against the other (obesity and diabetes), with a type 2 immune mechanism influenced by sex-dependent interactions between two immune cell subsets, macrophages and eosinophils, and secreted protein RELMa. We propose to investigate this immune axis with the goal to identify macrophage and eosinophil subtypes that govern sex-specific regulation of obesity and type 2 immunity and provide novel targets and mechanisms to treat obesity and helminth infection associated co-morbidities.